Hormone signaling and translation control in advanced prostate cancer

ABSTRACT (from parental grant)
The recent advent of highly potent inhibitors of the androgen receptor and androgen biosynthesis has had the
unfortunate iatrogenic effect of fueling new lethal prostate cancer phenotypes in patients. In particular, non-
neuroendocrine androgen receptor-low castration resistant prostate cancer (CRPC), an aggressive form of this
disease, is increasing in occurrence amongst patients and is uniformly fatal. The main barriers against
therapeutic advances are a paucity of relevant disease models and a very poor understanding of the
mechanisms that give rise to this phenotype. The process of protein synthesis has long been considered
subordinate to alterations at the levels of DNA and RNA in cancer etiology. However, work from our laboratory
and others have revealed that protein synthesis control is a dynamic process that coordinates not only bulk
mRNA translation, but also the specialized translation of distinct mRNAs important for cancer phenotypes.
Recently, our laboratory has developed and characterized a new in vitro and in vivo toolkit of both human and
murine androgen receptor-low CRPC. We have used these models to discover a critical link between androgen
receptor signaling and the process of mRNA translation initiation, which is critical for androgen receptor-low
CRPC growth. We hypothesize that androgen receptor-low CRPC is driven by the specific translation of
distinct mRNA networks, thereby leading to persistent tumor growth, which may represent a therapeutic
vulnerability. Our long-term objective is to utilize state-of-the-art mouse models, ribosome profiling, and patient
derived xenografts to definitively investigate the fundamental link between the androgen receptor and protein
synthesis control in a highly relevant and newly emerging disease course for prostate cancer patients. To do
so, we will address the following aims: 1) determine the mechanism by which the androgen receptor
communicates with the translation apparatus, 2) delineate how aberrant protein synthesis drives the translation
of distinct oncogenic mRNAs, and 3) elucidate the therapeutic efficacy of targeting translation initiation in
androgen receptor-low CRPC.
Ultimately, these studies are poised to uncover a new paradigm for gene regulation in androgen receptor-low
prostate cancer and provide the preclinical basis for targeting the protein synthesis apparatus in an
increasingly common highly aggressive disease.

Public health relevance
PROJECT NARRATIVE (from parental grant) A new highly drug resistant form of aggressive prostate cancer characterized by no neuroendocrine features and low androgen receptor (AR) levels is on the rise and very little is known about the cellular processes that govern its growth. We have discovered that the steps of protein synthesis are absolutely critical for AR low prostate cancer cell proliferation in vitro and in vivo, which represents a potential therapeutic vulnerability. Our goal is to definitively investigate the fundamental link between AR and protein synthesis and determine the therapeutic implications of targeting this interface.